Mechanistic investigation of multispecies interactions in clear aligner induced periodontal inflammation

Abstract
Clear aligner treatment can lead to oral microbial shift which may impact periodontal health. The interplay
between microbes and the host plays critical roles in health and diseases. However, a mechanistic understanding
of how the shifted microbiome (dysbiosis) and its interaction with the host influence oral health is still lacking.
Our preliminary studies demonstrated the increased relative abundance of Fusobacterium nucleatum (Fn),
Actinomyces spp. and Saccharibacteria (TM7) positively correlated with the progression of gingivitis in clear
aligner patients. Spectral FISH imagining of clinical samples and in vitro co-aggregation analysis indicated a
close physical association between Fn, Actinomyces spp., and TM7. More importantly, we provided new
preliminary data to demonstrate the potential synergy among the three bacterial species via physical interaction
and metabolic cross-feeding. The proposed study focuses on these three species which have a myriad of
virulence factors relevant to oral and systemic diseases and positively associated with periodontal inflammatory
diseases. These intriguing findings serve as the scientific premise for the working hypothesis that Fn,
Actinomyces spp. and TM7 may engage in synergistic interactions to enhance their growth within biofilm and
exhibit cooperative effects when interacting with host oral epithelial cells to promote inflammation. The well-
studied type strains Fn ATCC 23726, A. odontolyticus XH001 and Nanosynbacter lyticus strain TM7x, which
represent Fn, Actinomyces spp., and TM7, respectively, will be used in this study. Two independent but
interconnected aims are developed to test the working hypothesis:
Aim 1. Investigate the synergism between Fn, A. odontolyticus, and TM7 during biofilm formation. Using
Fn 23726, XH001 and TM7x model strains, comprehensive imaging-based analysis will be employed to
investigate the synergistic interaction during biofilm growth by assessing biofilm biovolume, maximal thickness,
roughness correlation ratio, and continuity ratio via confocal laser scanning microscopy (CLSM).
Aim 2. Examine the cooperative effects between Fn, A. odontolyticus, and TM7 when interacting with
host oral epithelial cells. We will use an in vitro culture system with various combinations of Fn 23726, XH001
and TM7x wildtype strains in the presence or absence of human oral keratinocytes (HOK-16B) to identify genes
with expression changes specifically attributable to the synergy of three species during interactions with HOK-
16B cells and determine if tri-species interaction has cooperative effects contributing to gingival inflammation.
The successful completion of these aims will provide novel mechanistic-level insight into the impact of microbial
shift during treatment with clear aligners on periodontal health. More importantly, the study will help identify the
molecular targets involved in polymicrobial synergy contributing to periodontal disease initiation/progression for
potential therapeutic purposes in the future.

Public health relevance
Project Narrative Fusobacterium nucleatum, Actinomyces spp. and Saccharibacteria (TM7) are frequently reported to have significantly increased abundance in inflammatory diseases, including clear aligner-associated gingival inflammation. This study investigates their interaction in relationship with gingival inflammation. It will provide molecular insight into these tri-species interactions and lay the foundation for therapeutic interventions against gingival inflammation.